Lactate as a regulator of Alzheimer's pathology

Project Summary/Abstract
The goal of this proposal is to understand how shifts in microglial metabolism impact the progression of
Alzheimer’s disease (AD) and whether targeting metabolic flux reduces Alzheimer’s-related pathology. Work
from our group and others now illustrates that alterations in glucose metabolism are central to Alzheimer’s
disease. While regional hypometabolism is a hallmark of later stage neurodegeneration, recent studies suggest
subtle shifts in metabolism occur much earlier in presymptomatic AD. FDG-PET neuroimaging is the gold
standard for assessing brain glucose uptake in AD yet lacks the sensitivity to detect cell specific changes or
the fate of glucose following cellular uptake. This causes a fundamental gap in our knowledge regarding early-
stage changes in metabolism, what cell types drive these changes, and whether these changes are protective
or damaging to the brain. Microglia increase glucose uptake in response to amyloid-beta (Aβ) and undergo a
metabolic shift from oxidative metabolism to glycolysis with activation. We hypothesize that early metabolic
adaptations in AD are driven by microglial activation, causing increased glucose uptake and shifts in glucose
utilization toward a more glycolytic profile. Lactate is the metabolic end product of glycolysis and is produced in
excess during shifts from oxidative metabolism to glycolysis. Our preliminary data shows that brain and
interstitial fluid (ISF) lactate is chronically elevated in mice with amyloid plaques and blocking lactate
metabolism reduces ISF lactate and ISF Aβ. While the role of lactate in the brain and in AD is widely debated,
lactate has emerged as an essential metabolite and signaling molecule for the brain. However, little is known
about lactate as a regulator of immunometabolism and microglial activity in AD. Our preliminary data shows
that genes responsible for lactate production (Ldha) and lactate consumption (Ldhb) are highly expressed in
microglia and Ldha expression is elevated surrounding amyloid plaques. Together, this suggests that Aβ
aggregation leads to excess lactate production which we hypothesize is due to changes in microglial
metabolism and function. While initially protective, we hypothesize that these chronic shifts in microglial
metabolism exacerbate Aβ aggregation, neuroinflammation, and functional deficits. In this proposal, we will
determine the relative contribution of microglia to brain metabolism, lactate production, and metabolic flux.
Next, we will use a pharmacological approach to block excess lactate as a novel target to reduce Aβ pathology
and neuroinflammation. Lastly, using a genetic approach, we will selectively deplete lactate production in
microglia to explore the impact of microglial derived lactate on brain metabolism, microglia function, Aβ
pathology, and functional deficits.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is the 6th leading cause of death in the United States and is expected to triple by 2050. Work from our group and others now show that changes in metabolism are central to the development and progression of Alzheimer’s disease. There is a critical need to understand what cell types in the brain drive early changes in metabolism, how this affects Alzheimer’s progression, and whether these changes are a potential therapeutic target for this devastating disease.